Regulation of de novo purine synthesis by the MAPK/ERK pathway

PROJECT SUMMARY
Cells and organisms must coordinate their metabolic activity with changes in their nutrient environment. This
coordination is achieved via the signaling networks that integrate local and systemic nutrient inputs and relay
nutrient status to the control of cellular anabolic and catabolic processes. This task can be carried out by the
RAS-­RAF-­MEK-­ERK cascade, a signaling system that is commonly activated by various growth factors and
oncogenic events. In response to a mitogen factor such as the epithelial growth factor (EGF), ERK is activated
and promotes cell proliferation and differentiation by regulating activity of transcription factors involved in cell
cycle progression and proliferation. However, much less is understood about how ERK signaling directly controls
metabolic processes. Targeting the kinases RAF, MEK or ERK is currently a strategy employed to treat several
diseases including cancer, type 2 diabetes, metabolic disorders and neurodegeneration, however mechanisms
of resistance often occur. Therefore, elucidating the downstream targets of ERK and more specifically the
molecular mechanisms by which ERK signaling drives metabolism is of great interest in order to identify new
therapeutic strategies against ERK driven disease. Recently we discovered that the mechanistic target of
rapamycin complex 1 (mTORC1) stimulates synthesis of purines and pyrimidines de novo through different
molecular mechanisms. Nucleotides play a central role in metabolism at a fundamental and cellular level. Purine
and pyrimidine bases can be synthesized de novo or recycled through the salvage pathways. Nucleotides carry
packets of chemical energy (e.g. ATP, GTP) throughout the cell to the many cellular functions that demand
energy, which include: synthesizing nucleic acids, proteins and cell membranes. Under this proposal, we propose
to study the influence of ERK signaling on nucleotide synthesis. We have identified that ERK signaling stimulates
de novo purine synthesis in various settings through posttranslational modification of the enzyme PFAS
(phosphoformylglycinamidine synthase) which belongs to the de novo purine synthesis pathway. We propose to
dissect the molecular mechanisms underlying this regulation (Specific Aim1). We will determine the role of the
ERK-­PFAS axis in the control of cell growth (Specific Aim 2). Furthermore, we will determine the implication of
this regulation in ERK-­mediated biology and disease (Specific Aim3). Thus, the overall goal of this proposal is to
decipher the molecular mechanisms by which ERK controls de novo nucleotide synthesis in normal and
pathological settings. We anticipate that the proposed studies will yield new insights into how nucleotide
synthesis is regulated by ERK and will uncover therapeutic targets to perturb ERK-­mediated disease.

Public health relevance
PROJECT NARRATIVE Given the involvement of ERK signaling in several diseases including Alzheimer disease, diabetes, obesity and cancer, this proposal will establish a new level of understanding of how ERK directly regulates activity of the metabolic pathways essential for cellular homeostasis. Our preliminary data place us in the unique position to uncover and understand at a biochemical and molecular level new regulatory processes, new biomarkers and new potential strategies that are needed for personalized therapeutic intervention in metabolic diseases that can be driven by improper ERK signaling.